The Chemistry-Biology Interface Program at Johns Hopkins University

Project Summary
Training at the chemistry biology interface at Johns Hopkins University will be made possible by
an independent Ph.D.-granting program that will nucleate a vibrant community of 31 faculty spanning
4 schools and 9 departments. Together, these faculty share a common approach of applying chemical
principles and methods to problems of profound importance to biology and medicine. The program
offers opportunities to develop research skills applicable over a wide range of dimensions, from single
molecules to complex macromolecular assemblies to whole cells. Laboratories are well funded and
focus on mentoring graduate students in rigorous, ethical and independent design and interpretation
of experiments in preparation for leadership roles in biomedical research. The highly collaborative
nature of Johns Hopkins provides students with access to many faculty and a robust infrastructure
of instrumentation and expertise.
Prospective students will be actively recruited from across the country to generate a highly
qualified pool of applicants that draw from small colleges, large universities, minority serving
institutions and historically black colleges and universities. Admission relies on a holistic review of
applicants' dedication to science, research experience, perseverance and academic success within the
context of available opportunities. Both diversity and inclusion are core values of this program. A
target of seven students will matriculate annually with support from the training grant. A matching
number of positions will be provided by the university to support students in their second year before
obtaining fellowships and assistantships for the remainder of the program. Annual cohorts will share
a common core curriculum created to reinforce a strong foundation in chemistry while building an
aptitude for the biological sciences through a rich selection of electives. A series of three laboratory
rotations across different departments will ensure a breadth of experience in research prior to
selection of a thesis advisor. Students will join together monthly for meetings on research and
professional topics and yearly for student-hosted seminars and a retreat.
Training progress of each student will be monitored carefully by a thesis committee to assure a
growing proficiency in independent and reproducible experimental design, keen observation, precise
data analysis and critical interpretation. Professional development will be enriched by a new course
in literature evaluation, proposal writing and public presentation and another course on career
planning. The goals of this train program foster original research contributions of high impact while
preparing young scientists for sustained success in their chosen career related to research.

Public health relevance
Narrative The principles of chemistry describe the molecular interactions that define life and distinguish between sickness and health. Consequently, a chemical approach to biomedical research reveals the fundamental basis for proper cellular function and the potential for misfunction. The Chemistry Biology Interface Program trains the next generation of scientists to apply the knowledge of chemistry to questions of biological and medical significance.